Creating a system for meeting and sustaining the use of the Volunteer Retail Food Program Standards (VRFPS) via a Community of Practice Model

Project Summary Project proposal OCPHS proposes to use the principles of a community of practice model to: ? Assist retail food regulatory programs in meeting the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS), and ? Reduce the number of out-of-control foodborne illness risk factors in the establishments they regulate by using the principles of active managerial control. Long-term objective Local retail food protection programs that use this model will: ? Increase the number of VNRFRPS criteria they meet, and ? Reduce the number of uncontrolled foodborne illness risk factors in the retail establishments they regulate. Aims ? Explore the effectiveness of a community of practice model in increasing the number of VNRFRPS criteria met by participating agencies. ? Develop a systematic approach for meeting the VNRFRPS that can be integrated into the daily operations of a retail food regulatory program of any size. ? Increase active managerial control of foodborne illness risk factors in the retail food setting by further refining PTV methodology*, and disseminating it to other retail food regulatory programs and to the retail food industry. *PTV Methodology- a risk-based approach to evaluating and promoting active managerial control of foodborne illness risk factors developed by Olmsted County Public Health Services (OCPHS). Through a cooperative agreement with FDA between 2012 and 2017, OCPHS has developed a PTV package that can be used by other agencies to implement the methodology.

Public health relevance
Project Narrative: The proposed project strategy has significant relevance to the field and practice of public health. In addition to continuing to promote the expanded use of a risk-based methodology by retail food protection programs in order to focus on the reduction of risk factors known to cause or contribute to foodborne illness, the development and evaluation of the use of a Community of Practice model by different sized agencies has the potential to advance the conformance with the Voluntary National Retail Food Regulatory Program Standards. Ultimately supporting each agency’s capacity to protect the public’s health through the promotion of the active managerial control of foodborne illness risk factors in the retail food setting.